Identification of botanical hHv1 channel blockers as analgesics for neuropathic pain

PROJECT SUMMARY
Relevance to public health. Microglia, the inflammatory cells in the brain and spinal cord, participate in the
development of neuropathic pain (NeuP) after nerve injury by releasing reactive oxygen species (ROS) and
proinflammatory cytokines. NeuP affects >16 million Americans, is associated with a severe reduction in quality
of life. NeuP is often refractory to conventional analgesics, and opioids have only limited efficacy increasing the
risk of their misuse. Medications not typically used as analgesics are often the first-line treatment of NeuP. How-
ever, <50% of patients report pain relief with current treatment, and side effects are common. We offer evidence
that suppressing the voltage-gated proton channel (Hv1) in microglia can reduce inflammatory mediators release
and attenuate NeuP. We propose to identify small-molecule Hv1 blockers by high-throughput screening (HTS)
of plant extracts and botanical compounds as a step toward new drugs for NeuP.
Brief background. This application builds on: (i) our publication that Hv1 controls ROS and proinflammatory
cytokines release in microglia and contributes to the development of NeuP, (ii) our preliminary finding that C6, a
designer peptide blocker of Hv1, suppresses ROS and proinflammatory cytokine release by microglia and atten-
uates NeuP after peripheral nerve injury in mice, and (iii) our successful pilot screening of a small compound
library and eight exemplar plant extracts using a novel live-cell, fluorescence-based HTS assay. The HTS assay
employs a pH-sensitive fluorescent protein genetically linked to the human Hv1 channel (hHv1-VFP-H148G),
allowing real-time monitoring of Hv1 operation and the identification of Hv1 blockers.
Unique features and innovation. Our target choice is innovative because no clinically approved drugs se-
lectively target microglia and Hv1 lacks potent and specific small-molecule blockers. Our HTS assay is innovative
because there is no reported HTS method for proton channels. We identified unique reagents: C6 (the first
specific blocker of Hv1), C6 variants, F6 (a small molecule that inhibits Hv1 in the HTS), and Lavender (a plant
extract that inhibits Hv1 in the HTS) to facilitate the development, refinement, and validation of the HTS assay.
We will employ the HTS assay to screen a unique plant extract library with >1,500 species (with >15,000 esti-
mated compounds), many of which have been used historically for anti-inflammation and pain-relief.
Three specific aims. (1) Optimize the HTS assay (R61 phase) seeks to improve and validate the HTS assay
for plant extracts and botanical compounds. (2) Select leads from a unique library of plant extracts (R33 phase)
seeks to screen the plant extracts library and identify potent and specific botanical Hv1 blockers. (3) Study sup-
pression of the microglial inflammatory response and NeuP with identified botanical Hv1 blockers (R33 phase)
seeks to validate the efficacy of identified botanical Hv1 blockers in microglia cells and a mouse model of NeuP.
Significance. This work addresses an unmet medical need for NeuP therapeutics and has a broader influ-
ence because Hv1 in microglia is complicit in additional inflammatory disorders, such as ischemic stroke.

Public health relevance
PROJECT NARRATIVE This research addresses a specific unmet medical need, the absence of effective therapeutics for neuropathic pain (NeuP), a debilitating chronic pain syndrome that develops as a result of nerve injuries caused by trauma or disease and affects over 16 million Americans. This proposal seeks to optimize a novel fluorescent high- throughput screening (HTS) assay for identifying small molecule blockers of the voltage-gated proton channel (Hv1) from botanicals that reduce the release of inflammatory mediators by microglia and thereby relieve NeuP. The project will build on preliminary findings to optimize the HTS assay and identify lead compounds for devel- opment as drugs targeting Hv1; these agents will have a number of other potential uses because Hv1 is central not only to the development of NeuP but also contributes to tissue damage after ischemic stroke and spinal cord injury.